A pilot study to define maintained alterations in mitochondrial DNA of eosinophilic esophagitis patients that may be exploited clinically

Project Summary
Eosinophilic Esophagitis (EoE) is a chronic, food antigen-mediated disease characterized by eosinophil-rich
esophageal inflammation and symptoms such as abdominal pain, dysphagia and food impaction. A recent
study identified damaging variants in the gene encoding the mitochondrial protein DHTKD1 in EoE patients.
Although this indicates a potential role for mitochondria in EoE pathobiology, it remains unclear whether
alterations in mitochondrial DNA are present in EoE and may be leveraged to improve clinical care of EoE
patients. Indeed, mitochondria house reactive oxygen species (ROS)-producing electron transport chain
components and have less sophisticated DNA repair mechanisms as compared to nuclear DNA, making
mitochondria DNA highly susceptible to ROS-induced genetic alterations. This information in concert with our
preliminary findings indicating (i) that there is an increase in mitochondria in esophageal epithelium of patients
with active EoE that fails to normalize in inactive EoE patients; and (ii) mitochondrial dysfunction is induced in
esophageal keratinocytes upon exposure to the EoE inflammatory milieu, led us to hypothesize that alterations
in mitochondrial DNA may be acquired in esophageal mucosa of patients with Active EoE and maintained in a
subset of Inactive patients in clinical disease remission. To test this hypothesis, we will pursue the following
specific aims: Aim 1: Perform mitochondrial DNA sequencing in biopsy specimens from a cross-sectional
cohort of human subjects comprising Normal controls as well as patients with Active and Inactive EoE.
Gastroesophageal reflux disease patients will be evaluated to determine whether identified mitochondrial DNA
alterations are specific to EoE. Aim 2: Perform mitochondrial DNA sequencing in biopsy specimens from a
longitudinal cohort of human subjects comprising patients with tissues available at the time of both Active EoE
and Inactive EoE and classified as therapeutic responders or non-responders. This study will (i) determine if
mitochondrial DNA damage is a feature of EoE, both Active and Inactive; (ii) assess the relationship between
mitochondrial DNA mutational burden and therapeutic response in EoE; and (iii) identify recurrent
mitochondrial mutations that may be targeted therapeutically in EoE. Examples of potential mitochondria-
targeted therapies for EoE include, delivery of antioxidant compounds (e.g. Coenzyme Q10) or micronutrients
(e.g. Zinc, Biotin) to improve mitochondrial function, enzyme replacement therapy to restore the function of
faulty enzymes encoded by mitochondrial DNA, and Adenoviral or CRISPR-mediated editing of the
mitochondrial genome. Data generated in this study will provide the foundation for a future NIH R01 proposal
that will delineate the functional significance of mitochondrial DNA alterations in EoE pathobiology and also
evaluate therapeutic strategies related to mitochondrial dysfunction using preclinical models, including primary
epithelial cultures, patient-derived esophageal organoids, and murine EoE models.

Public health relevance
Project Narrative Alterations in mitochondrial biology have been identified in a wide variety of human diseases, contributing to inflammatory signaling and tissue dysfunction while also emerging as a potentially fruitful area of focus for translational medicine. Here, we propose a pilot investigation to determine how inflammation impacts mitochondrial DNA in patients with the emerging food allergy Eosinophilic Esophagitis with the goal of identifying novel strategies to improve prognosis and therapy of this allergic disorder.